Cytoskeletal Function in C. elegans Embryos

We request funds to purchase two high capacity and versatile BioRad Thermal Cyclers.
These will replace a single much older and lower capacity thermal cycler currently
shared by my lab and the adjacent labs of my nearby colleagues and faculty members
Chris Doe and Diana Libuda. Currently, due to the age of our machine and its limited
capacity, and a lack of other institutional options, we have suffered from lack of access
to amplification for constructing transgenic strains we need for our research. The
discovery of CRISPR/Cas9 and its applications to genome editing have revolutionized
molecular genetics in all systems, including C. elegans, and our limited thermal cycler
capacity is now frequently limiting and slowing our progress. By purchasing two new
higher capacity machines, and having a shared arrangement with two other labs, we will
relieve not only the limitation to access in my own lab but also in the labs of two of my
closest and physically adjacent colleagues. The remarkable advances in high resolution
light microscopy make our ability to generate fluorescent protein fusions to endogenous
loci more and more powerful, and we also are implementing more highly mechanistic
structure/function studies that require the creation of transgenic lines that express
mutant transgenes to replace endogenous genes. Finally, we also are now beginning to
use optogenetics to more rigorously explore gene requirements. We need increased
thermal cycler capacity to generate transgene constructs for use in all of these powerful
molecular genetic approaches.

Public health relevance
This administrative supplement request, for R35GM131749, requests additional funds to purchase two BioRad thermal cyclers that we need to replace our single, shared, aged and low-capacity machine that is insufficient to meet our current needs. This has become even more urgent recently, given our greatly increased use of CRISPR/Cas9 genome editing technology. We will use the thermal cyclers to generate fluorescent protein fusions to endogenous loci, to generate mutant transgenes for structure/function studies in vivo, and to execute optogenetic experiments designed to advance our understanding of protein function, all during the fundamentally important biological process of animal oocyte meiotic cell division.